Layer 6b, a novel inhibitory gain controller in the neocortex

Project summary
Cortical excitatory and inhibitory (E/I) imbalance in the brain has been commonly
observed in psychiatric disorders. However, neither circuit mechanisms or cell types responsible
for the E/I imbalance in the disease are clearly specified. We focus on layer 6b (L6b) neurons as
a strong candidate for cortical inhibitory gain controller. Although L6b neurons, also called
subplate neurons, are previously known to show abnormal distribution in postmortem brain
tissues of schizophrenia (SZ) and autism-spectrum disorders (ASD), the anatomy and
physiology of the neurons are poorly understood. Our optogenetics-based slice
electrophysiology and in vivo two-photon axonal calcium imaging demonstrate that these
neurons persist in adult brains, project axons toward up to layer 1 by crossing all six cortical
layers, innervate inhibitory interneurons, form functional synaptic connection within cortical
circuit, and respond to external sensory stimuli. More interestingly, our preliminary data found
that the number of neurons in layer 6b (L6b) was decreased in a mouse model of a CNV,
16p11.2 duplication which is known to show deficient GABAergic synaptic transmission and
highly associated with SZ and ASD. These data suggest that L6b neurons may play a key role
in cortical gain control via feed-forward inhibition and the dysregulation of these neurons may
cause psychological and behavioral symptoms. We will determine this innovative hypothesis,
L6b neuron as a novel inhibitory gain controller in the neocortex and they are responsible for
cortical imbalance in psychiatric disorders. We will combine multiple approaches including
optogenetics-based multiple whole-cell patch clamp recordings, in vivo calcium imaging, and
pharmacogenetic manipulation of the L6b neurons to determine the roles of the L6b neurons
and their implications in pathological conditions. Our proposed work will provide a new
conceptual understanding of dysregulated cortical inhibition in psychiatric disorders, by
presenting L6b neuron as a key cortical gain controller.

Public health relevance
Narrative Cortical excitatory and inhibitory (E/I) imbalance in the brain has been commonly observed in psychiatric disorders. Inhibitory dysregulation is known to cause the E/I imbalance in the cortex and lead to psychological and behavioral symptoms in the disease, but the underlying circuit mechanisms are not yet understood. By elucidating the roles of layer 6b as a novel gain controller in cortical inhibition, this project will determine whether and how these neurons contribute to cortical inhibitory network and how dysregulation of layer 6b leads to psychological and behavioral alterations.